Dynamics and evolution of cell cycle transitions

DESCRIPTION (provided by applicant): The ability of a cell to grow and divide in variable environments is contingent on its ability to sense and respond appropriately to external change. Throughout eukaryotes, mitogen activated protein kinase pathways (MAPK) are frequently used to link external changes to downstream cellular responses, which necessarily includes cell cycle regulation. In this proposal, we focus on control of the cell cycle by the pheromone-induced MAPK pathway in budding yeast. Information about pheromone concentration is integrated in G1 phase, prior to the 'Start' of the cell cycle. Whereas pre-Start early G1 cells arrest their cell cycle directly when exposed to mating pheromone, post-Start late G1 cells are unaffected until the subsequent cycle. Due to our extensive molecular knowledge of both the genes involved and their biochemical interactions, Start serves as a model for cell cycle commitment in eukaryotes. Here, we aim to apply dynamical systems theory to attain a comprehensive understanding of checkpoint control and advance our understanding of genetic circuits governing cellular transitions. More specifically, we aim to understand how genetic circuits are implemented to generate mutually exclusive cell fates, and, once a particular fate is selected, how large transcriptional programs are seamlessly actuated to effect cellular transitions. Across yeasts, the core function of the genetic control network at the interface between the pheromone-induced MAPK pathway and the cell cycle, i.e., to separate mating from mitosis, remains unchanged. However, there has been dramatic evolution of the components of both the cell cycle and MAPK pathways. By initiating a parallel set of experiments using the fission yeast model, we aim to investigate the hypothesis that evolution has acted to conserve the dynamical systems properties rather than the individual parts of the regulatory network. Our experimental program is comprised of both single-cell microscopy and novel bioinformatic algorithms to analyze genome-wide datasets. Notably, we employ a microfluidic platform that allows time-lapse phase and fluorescence imaging during rapid exposure to mating pheromone. Our algorithms and analysis will be applicable to a wide range of systems.

Public health relevance
PUBLIC HEALTH RELEVANCE: Genes involved in the core processes of cell cycle control are frequently mutated in cancers. Since cell cycle regulation is highly conserved across eukaryotes, the concepts and techniques developed in the proposed research are likely to provide a broader and deeper understanding of the human system and to give insight into oncogenesis. Project Narrative Genes involved in the core processes of cell cycle control are frequently mutated in cancers. Since cell cycle regulation is highly conserved across eukaryotes, the concepts and techniques developed in the proposed research are likely to provide a broader and deeper understanding of the human system and to give insight into oncogenesis. __SpecificAimsTextDelimiter__ Title: Dynamics and evolution of cell cycle transitions. A. Specific Aims A key cell cycle checkpoint governs commitment to cell division across eukaryotes. Using yeast models, we aim to apply dynamical systems theory to attain a comprehensive understanding of checkpoint control and advance our understanding of genetic circuits governing cellular transitions. More specifically, we aim to understand how genetic circuits are implemented to generate mutually exclusive cell fates (A1), and, once a particular fate is selected, how large transcriptional programs are seamlessly actuated to effect cellular transitions (A2). A1. On the interface between cell cycle control and mitogen activated protein kinase (MAPK) signaling. By employing an integrated modeling and experimental approach, we aim to uncover the dynamical systems properties and principal biochemical interactions controlling the interface between pheromone-induced MAPK signaling and the cyclin dependent kinase driven cell cycle. Our experimental program is centered on a microfluidic platform that allows time-lapse phase and fluorescence imaging during rapid exposure to mating pheromone. A1.1. To identify the properties of the dynamical system ensuring separation between the mitotic cell cycle and pheromone-induced arrest in budding yeast. The G1 checkpoint Start determines if a cell enters the mitotic cycle or engages the mating program since performing both together is poorly compatible. At Start, the upstream cyclin-Cdk complex (Cln3-Cdc28) initiates a transcriptional positive feedback loop of two more G1 cyclins (Cln1 and Cln2), which ensure cell cycle progression. In the presence of mating factor, a MAPK pathway activates Far1, which inhibits G1 cyclin activity. The inhibition of Far1 and the MAPK cascade scaffold protein Ste5 by Cln1 and Cln2 suggests a double negative feedback system that may be bistable, which would be an efficacious way to generate mutually exclusive cell fates. [Hypothesis 1.1: The interface between pheromone-induced arrest and the mitotic cell cycle in budding yeast is a bistable dynamical system] A1.2. To identify conserved system-level properties at the interface between MAPK signaling and the cell cycle. Across yeasts, there has been dramatic evolution of the components of both the cell cycle and MAPK pathways. We aim to investigate the hypothesis that evolution has acted to conserve the dynamical systems properties of the pheromone-induced MAPK cell cycle interface rather than the individual parts of the regulatory network. We will develop a quantitative single-cell assay for cell cycle commitment in the fission yeast S. pombe to uncover the dynamical system properties of the mating-mitotic switch as in A1.1 for budding yeast. The comparative study of the two yeast systems aims to reveal conserved features of this important regulatory network. [Hypothesis 1.2: Dynamical systems properties, such as bistability, are conserved across fungi. We will address this question by a direct experimental comparison of the orthologous mating-mitotic switches in budding and fission yeasts.] A2. On regulon organization at cell cycle transitions. Once a cell fate is selected, the corresponding transcriptional program must be faithfully actuated. Since transcription of a single gene can be a noisy stochastic process in individual cells, the synchronous induction of a regulon comprising ~200 genes, as occurs during cell cycle entry, poses a potentially difficult problem. Our previous work suggested a model in which full regulon expression occurs only after feedback loop activation to avoid superfluous transcription in cases where the mitotic cell cycle is not engaged. To measure genome-wide actuation dynamics at Start, we aim to develop novel bioinformatic algorithms that will use cell cycle synchronized microarrays and transcriptome sequencing to robustly measure gene induction and subsequent inactivation. These datasets will be used to identify features of promoter architecture that give rise to differential induction. Our algorithms and analysis will be applicable to any high-throughput time-course. [Hypothesis 2: Large-scale transcription of the entire G1/S regulon occurs only after cell cycle commitment, ensuring against unnecessary gene expression.]